Developing and pilot testing an eHealth decision support tool for young trans women to improve informed decision making about PrEP

Project Summary
Transgender women (TW) have the highest rates of new HIV infections in the US yet are less likely to be aware
of, use, or adhere to PrEP. This is especially worrisome as new modalities beyond daily oral (i.e. injectable,
longer acting pills) are quickly coming on the market, making decision making and clarifying preferences crucial
to uptake. Importantly, missing in much of the research on barriers to PrEP uptake are the voices of young (15-
24) trans women (YTW), who may also experience age-related barriers to PrEP decision making, such as
confidentiality and conflicts with family during transition, and lack of a supportive community with credible
spokespeople whom they trust. No interventions have developed decision support tools (DSTs) to help YTW
make decisions about PrEP in line with their individual preferences and cultural values delivered in non-
traditional venues that meet YTW where they are. The primary goal of this study is to develop and evaluate the
feasibility, acceptability and promise of efficacy of an electronic health DST called QUEEN-P (QUestions to
Empower and ENgage with PrEP) to increase PrEP informed decision making among YTW in Philadelphia.
Using commercial marketing techniques – perceptual mapping and vector message modeling – and grounded in
the Ottawa Decision Support Framework, QUEEN-P will be delivered via tablets or other devices in novel
locations (mobile vans, house and ball events), working with community partners known to be trusted by YTW.
Specific aims are: 1. Assess YTW perceptions of PrEP, different delivery methods and potential barriers to
initiation and adherence. We will establish community and scientific advisory boards (CAB/SAB) made up of
YTW and healthcare providers and community advocates, survey YTW (n=100) and use perceptual mapping
analyses to develop targeted messages, elicit feedback from the CAB/SAB on content and delivery of QUEEN-P;
2. Develop the QUEEN-P eHealth DST and assess usability and acceptability. We will develop a prototype DST
and concept-test messages and features with our CAB/SAB for feedback on acceptability, revise it based on
feedback and conduct user testing with YTW (n=20); 3. Pilot the intervention to assess for promise of efficacy in
engaging YTW in PrEP informed decision making and assess interest in and outreach to community clinical
partners for PrEP. We will conduct a pilot test with YTW (n=60) in Philadelphia randomized to an “Enhanced”
(QUEEN-P + navigation to culturally competent PrEP providers) or “Basic” study arm (basic PrEP information
and a list of resources). To assess promise of efficacy, we will compare outreach to clinical partners and
decisional conflict (primary outcomes) at 3-month follow-up and assess decision preparation, self-reported
knowledge and attitudes, and PrEP uptake (secondary outcomes; immediate post, 3 month follow-up).
Qualitative exit interviews will inform feasibility and acceptability. This pilot study will examine the potential
impact of using technology based, salient, gender-responsive interventions to improve PrEP informed decision
making in a population at high risk of HIV acquisition.

Public health relevance
Project Narrative As PrEP delivery methods change, decision making about how best to use PrEP and the pros and cons to each is important, especially for young trans women ages 15-24 who are less likely to use PrEP and have significant barriers to advocating for their wishes in a healthcare setting. Decision support tools designed to consider and address specific concerns and information gaps young trans women have related to PrEP and its delivery methods could support better informed decisions and empower them to try PrEP. We will develop and pilot test the web-based QUEEN-P decision support tool in young trans women to assess acceptability, feasibility and promise of efficacy in supporting informed decisions around PrEP and clarifying values in method delivery.